COBRE CORE B: DMS: MOLECULAR BIOLOGY CORE/IMMUNE MONITORING LABORATORY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The Immune Monitoring Core Facility will provide cytokine analysis and other immunoassays needed for studies described in the individual projects of the Program. The Core Facility provides immunoassays for both human and mouse cells.